Innate Immunity, Cholesterol, and NASH Pathogenesis

PROJECT SUMMARY /ABSTRACT
Non-alcoholic fatty liver disease (NAFLD) is the most common cause of chronic liver disease, affecting at least
a quarter of the world’s population, and therefore highly relevant to the NIH mission. From steatosis to fibrosis,
hepatic inflammation drives disease progression, and this study will elucidate the central roles of cholesterol.
The lack of evidence-based, FDA-approved treatment options for NASH underscores the need for further
research into understanding disease pathogenesis and identifying potential targets. Our compelling preliminary
and recently-published findings demonstrate innate immune cells (neutrophils and macrophages) are central to
the pathogenesis and progression of NAFLD. The overarching hypothesis of this proposal is that dysregulation
of innate immunity and inflammation is a dominant, indispensable feature of NAFLD, largely mediated by
cholesterol. We will test this hypothesis through completion of three Specific Aims performed in parallel using
murine NAFLD models and samples from patients with varying severity of NASH. In SA1, the PI will
comprehensively characterize fresh peripheral neutrophils from patients with different stages of NASH. This will
include NETosis, how cholesterol-induced NETs license responses from macrophages and differential effect of
neutrophils on liver endothelial cells. Murine models will focus on targeting of NETs to attenuate hepatic injury
in NASH. We will use the FPC diet, rich in fructose, palmitate, trans-fat, and cholesterol (1.2% by wt), which
has been shown to induce hepatic fibrosis-associated parameters within 16 weeks. SA2 will use live mice fed
different FPC-based diets with isolation of hepatic tissue by ultrasound-guided fine-needle aspiration, followed
by single-cell RNA sequencing (scRNA-seq) to measure genome-wide expression of macrophages from
progressing or regressing diet-induced NASH. Our data demonstrate that withdrawal of high cholesterol in the
diet downregulates macrophage-specific transcription as early as 4 weeks. The proposed experimental plan will
provide unprecedented insights into how dietary cholesterol affects different hepatic macrophage populations.
We will also characterize the functional consequences of different hepatic macrophages on co-cultured hepatic
stellate cells (HSCs). Moreover, we will use targeted sequencing of promoter regions in macrophage genes in
order to define key adaptive changes in epigenetic regulation. Finally, in SA3, the PI will focus on integrating
these robust analyses and utilizing Cre-Lox system to generate mice with myeloid-specific targeted mutants of
genes. As we have found that osteopontin (OPN)-encoding SPP1 expression was strongly induced in
macrophages in NASH, we will test an OPN nanoparticle in prevention and reversal studies of diet-induced
NASH. Mice carrying the Col1a1-GFP transgene will be used to directly assess the effect of different therapeutic
strategies on activation, differentiation, and fibrogenic responses of HSCs. Taken together, our multidisciplinary
approach and outstanding synergism of experts has the potential to fundamentally change our understanding of
how cholesterol shapes and dysregulates innate immunity in NASH and identify novel treatments.

Public health relevance
PROJECT NARRATIVE Non-alcoholic fatty liver disease (NAFLD) is the most common cause of chronic liver disease in modern society. NAFLD is predicted to become the leading indication for liver transplantation and is a risk factor for the development of hepatocellular carcinoma that can develop even without cirrhosis. The lack of evidence-based, FDA-approved treatment options for NASH underscores the need for further research into understanding disease pathogenesis and identifying potential targets. Here, based on compelling preliminary and recently published data from our group, we propose to comprehensively study how the innate immune response mediates inflammation and fibrosis in mice and humans with NAFLD, providing novel insights into potential therapeutic targets.